VA HSR&D Center for the Study of Healthcare Innovation, Implementation & Policy (CSHIIP)

The mission of the VA HSR&D Center for the Study of Healthcare Innovation, Implementation & Policy
(CSHIIP) is to develop and test innovations that markedly improve the effectiveness and value of VA health
care, from system, provider, and Veteran perspectives, while advancing scientific methods for accelerating
adoption, implementation, spread, and scale-up of evidence-based practice. Our vision is to promote delivery
of proactive, personalized, and patient-driven care that is evidence-based and continuously improving. We will
leverage our 25-year focus on provider behavior and implementation science to achieve these priority goals:
Goal #1: To improve primary care delivery, with an emphasis on access, team function, and care coordination
in the context of VA’s medical home model (PACT) and medical neighborhood within and outside VA;
Goal #2: To increase implementation, accessibility, and impacts of gender-sensitive comprehensive care for
women Veterans through innovative care models and multilevel stakeholder engagement;
Goal #3: To improve care quality, patient experience, and outcomes among high-risk, high-need Veterans,
focused on subpopulations with serious mental illness, homelessness, substance use, as well as older adults,
and acute care patients;
Goal #4: To develop, test, and implement novel care models in emerging areas, including complementary and
integrative health/whole health, specialty care, and emergency management/disaster preparedness;
Goal #5: To recruit, train, mentor and retain researchers in our recognized areas of expertise, including health
systems interventions, implementation science, and partnered research; and
Goal #6: To accelerate our research impacts through strategic partnerships, Veteran and employee
engagement, implementation and dissemination, and internal evaluation and communication.
Leadership: CSHIIP is directed by Elizabeth M. Yano, PhD, MSPH, with overall responsibility for the Center’s
strategic plan, scientific oversight and successful engagement of the Center’s Executive Steering Committee
(ESC), academic affiliates, and principal VA partners. She is supported by Center Associate Director David
Ganz, MD, PhD, and Chief Officers for Administration (Gooding, Caraveo), Training (Saliba), and scientific
development in areas of Innovation and Dissemination (Taylor) and Implementation and Policy (Hamilton), as
well as a Leadership Committee of senior HSR&D investigators. Comprised of our principal partners, affiliates,
and experts in research, policy, and implementation, our ESC provides critical guidance on a regular basis.
Primary Partners and Major Collaborations: Our VA principal partners are the Offices of Primary Care
(Denietolis), Women’s Health Services (Hayes), and Organizational Excellence (Francis), VISN 22 (Revote),
and VA Greater Los Angeles. Affiliates include UCLA Schools of Medicine, Public Health and Nursing, and
RAND Health. Our investigators actively collaborate with PIs at all of the other COINs and half of the
CREATEs, being involved with 80+ VA medical centers in our multisite research and evaluation activities.
Research Areas: Goals 1-3 represent our focused areas and Goal 4 represents our emerging areas. We also
propose new research to improve employee experience, especially related to workplace safety issues (e.g.,
harassment of providers) that can profoundly affect employee engagement, resiliency, and retention.
Selected Accomplishments of Center Investigators: From FY15-17, we have leveraged Center core funding an
average of 19-fold across 125 research and operations projects. Core PIs have published 40% more papers
(426) than our previous 3-year total, contributed substantial VA service to research, operations, and policy, and
been widely recognized outside VA (e.g., National Academy of Medicine, NIH, AHRQ, PCORI, FDA, Centers
for Medicare and Medicaid Services, the National Quality Forum, and more). Center impacts range from
methodological advances and new care models to implementation/spread of new tools and policy changes.

Public health relevance
The VA HSR&D Center for the Study of Healthcare Innovation, Implementation & Policy (CSHIIP) has had a fundamental role in the ongoing transformation of VA health care, through critical examination of multilevel determinants of variations in VA care, development and testing of innovative healthcare delivery models that improve the effectiveness and value of VA care, and impact on VA practice and policy through implementation and spread of evidence-based practice. Our work is anchored in a longstanding history of high-impact research through career development, support, and engagement of a multidisciplinary cadre of investigators, leveraging extensive partnerships that have infused our mission, vision, and values with a deep understanding of VA priorities. These partnerships and priorities have guided our strategic planning, enabling us to build a portfolio of highly responsive research in key focused (primary care, women’s health, high-risk/high-need groups) and emerging areas (complementary/integrative health, specialty care, and emergency management).